DIRECT SINGLE TEST ANALYSIS OF LDL AND ALL LIPOPROTEINS

Of the risk factors associated with coronary artery disease, the most important is inherited dyslipoproteinemia, including elevated LDL. VAP, Inc. proposes to develop a nationwide network of referral laboratories for comprehensive lipoprotein testing based upon the VAP-II procedure. The goal is to provide a single test for diagnosis of abnormalities in the different lipoprotein classes, a test that will be cost effective enough for the physician to follow on a routine basis the effects of treatment on all lipoprotein classes. Commercial viability will depend upon the accuracy and reliability of a VAP-II test and its cost. Phase I: To develop VAP-II to the point that it is a commercially viable product, two specific aims are proposed in phase I: I) Complete the validation of the basic VAP-II system. 2) Develop the valve assembly and the meniscus detection components of a more automated VAP-II (AutoVAP-II). AutoVAP-II is of great important for developing a competitive cost structure for VAPII; a properly designed AutoVAP-II can reduce technician time by one- half to one-third, the major cost associated with the procedure. Phase II: To complete the development of the AutoVAP-II system, three specific aims are proposed: 1) Develop an automated centrifuge tube loading and puncturing system, 2) package the entire AutoVAP-II system into a single box, and 3) validate the finished product.